Novel Strategies for Assessing and Optimizing Therapy for Minimal Residual Disease after Allogeneic Transplantation for AML and MDS

PROJECT SUMMARY
Allogeneic hematopoietic cell transplantation (HCT) is an essential therapeutic procedure used to enhance the outcome of
patients with acute myeloid leukemia (AML) and myelodysplasia (MDS). Recent advances in alternative donor
transplantation and supportive care have allowed for a greater number of older adults and those with co-morbidities to
pursue potentially curative transplant procedures. In addition, the emerging era of targeted therapy allows for the
development of novel disease remission induction regimens as well as transplant conditioning regimens that can enhance
outcomes. However, relapse after allogeneic HCT remains a major barrier to successful outcomes, with recent data
suggesting that up to 50% of allogeneic HCT failure and mortality relate to persistence or relapse of underlying disease.
Recent advances in the detection of minimal residual disease (MRD) have enhanced the capacity of identifying some
patients at risk of relapse after HCT. Using information obtained by cytogenetics, fluorescence in situ hybridization (FISH)
and genomics, successful outcomes can still be achieved in a subset of myeloid malignancy patients transplanted in the
setting of morphologically active or MRD-detectable disease at the time of transplant. This proposal is a pilot study to
determine whether augmented genomic MRD assessment both before and after transplant for myeloid malignancies can be
used to guide clinical investigators into offering post-HCT therapy. In so doing we hope to establish the importance of both
pre- and post-HCT MRD and to begin to explore novel interventions for post-HCT MRD using a variety of cellular and/or
pharmacologic-targeted approaches.

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia and myelodysplasia patients account for nearly 6,000 stem cell transplant procedures annually in the US. Relapse after transplant is a major obstacle for assuring the long term effectiveness of these efforts and has high associated mortality. Our proposed investigations using post-transplant minimal residual disease measurement to guide intervention in these transplant recipients will improve outcomes and reduce the number of patients experiencing overt relapse.